Research Education for Future Physician-Scientists in Child Psychiatry

Research Education for Future Physician-Scientists in Child Psychiatry
R25 MH077823
This renewal application is aimed at continuing to prepare physicians for
independent careers in the investigation and treatment of childhood psychiatric
disorders. Such programs are urgently needed. This need is based on the large
number of children affected, the considerable costs to society associated with
their care, the limited effectiveness of available treatment and prevention
programs, the small number of physician-scientists active in the field, and the
potential for significant scientific advances in the foreseeable future. This grant
will make it possible for the faculty of the Yale Child Study Center, working with
the American Academy of Child and Adolescent Psychiatry (AACAP) and
academic leaders across the country, to continue to refine, evaluate and
disseminate this model research education program, which extends from the first
year of post-graduate medical education through post-doctoral research training
and the eventual submission of a K-series Career Development Award. Along
the way, participants will be encouraged to pursue advanced degrees. For
postdoctoral participants entering the Albert J. Solnit Integrated Child and Adult
Psychiatry Research Pathway at Yale, this award will permit us to continue
funding intensive periods of research training during a six-year program that
meets American Board of Psychiatry and Neurology accreditation for both adult
and child and adolescent psychiatry. There are currently 12 participants enrolled
at this Yale program, with two more having recently matched into its nineteenth
cohort (2022-2028). Five of the first ten eligible graduates of the program
graduated with successfully funded K Awards, and ten of the first twelve with
academic faculty appointments. Our program has had a strong track record of
attracting, recruiting and retaining physician-scientists from underrepresented
minorities. Similar integrated programs are currently underway at the University
of Colorado (since 2005) and the University of Vermont (since 2010).

Public health relevance
Project Narrative This renewal application is aimed at continuing to prepare physicians for independent careers in the investigation and treatment of childhood psychiatric disorders. Such training and education programs are urgently needed. This need is based on the large number of children affected, the considerable costs to society associated with their care, the limited effectiveness of available treatment and prevention programs, the small number of physician-scientists active in the field, and the potential for significant scientific advances in the foreseeable future.